PALYTOXIN PRODUG ACTIVATION BY ANTIBODY-LINKED ENZYME

DESCRIPTION: (Adapted from applicant's abstract) Palytoxin prodrug derivatives which can be activated by antitumor monoclonal antibody-enzyme conjugates will be prepared and tested for antigen-selective cytotoxicity.